APPLICATION PROJECT: “NEUROCHEMICAL PROFILE” IN ANIMAL MODEL OF SCHIZOPHRENIA

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The goal of this project was to determine changes in the nerucoehmical profile following PCP administration, which is used as an animal model of schizophrenia.